EFFECT OF CONTINUOUS GLUCAGON INFUSION ON 24H GROWTH HORMONE SECRETORY PROFILE

Compare pulsatile GH secretion and GH response to GHRP in fasted subjects during glucagon and saline infusions. Each subject will be studied twice and will serve as his own control. During the 27 hour infusions, blood samples for GH wil be obtained at 5 min intervals.